Systems Genetics Approach to Intracranial Aneurysms

PROJECT SUMMARY
Aneurysmal subarachnoid hemorrhage (SAH) is caused by ruptured intracranial aneurysms and affects a
predominantly young population and results in a large number of productive life years lost with a high
associated lifetime cost. Aneurysmal SAH carries a poor prognosis with greater than 50% mortality and only
25% of survivors with good outcome. Because a devastating hemorrhage is usually the initial presentation and
because of the young population involved, cost-effective early detection of unruptured aneurysms that will lead
to more focused screening is of paramount importance. The genetic basis of aneurysm formation has been
confirmed by genome-wide association studies in which a number of associated genes have been identified.
However, the genetic variants identified in these studies explain only a fraction of the phenotypic variance,
suggesting the involvement of other genetic and epigenetic mechanisms. We hypothesize that both genetic
and epigenetic changes are crucial components of aneurysm formation and aim to identify the key pathways
involved using a systems genetics approach. Our research will provide mechanistic insights into the
epigenetic/genetic targets in aneurysm formation which may lead to the development of novel therapeutic
strategies and provide a cost-effective means to identify individuals at high risk of aneurysm formation.

Public health relevance
PROJECT NARRATIVE Subarachnoid hemorrhage from ruptured brain aneurysms is a devastating disease that affects predominantly middle-aged adults. The goal of this study is to further understand the mechanisms behind the formation of aneurysms and thereby develop new treatments as well as a blood test for early detection of individuals at risk for aneurysm formation.